Project 3

ABSTRACT/SUMMARY:
Hereditary spastic paraplegias (HSPs) are a diverse group of over 80 rare neurogenetic disorders, representing
the most common cause of inherited spasticity and related disabilities worldwide. All HSPs are characterized by
progressive lower limb spasticity, weakness, and significant motor impairment. Clinical Research Project 3 aims
to create and validate digital biomarkers that accurately reflect disease progression in HSP, enabling more
sensitive and specific outcome measures for clinical trials. Wearable activity monitors and inertial sensors as
digital surrogates gather details about disease manifestations in a more individualized and finer-grained way,
using sophisticated algorithms harnessing artificial intelligence and machine learning to integrate the resulting
wealth of data with other kinds of clinical information. This type of deep phenotyping will provide more specificity,
new types of big data, and potential connections between HSP subforms and genetic variations, in support of
the genetic Project 2. In summary, Project 3 will significantly improve ‘clinical trial readiness’ for multiple forms
of HSPs, add layers of digital phenotypes for improved stratification of different HSP subforms, and potentially
simplify future clinical trial data collections - thus aligning with and especially support the goals of Clinical
Research Projects 1.